Expanding access and accelerating delivery of interventions to promote mental health for underserved adolescents

OVERALL PROJECT SUMMARY
The overall goal of our transdisciplinary center for Expanding Access and Accelerating Delivery of
Interventions to Promote Mental Health for Underserved Adolescents (ACCESS) is to improve the mental
health of underserved youth, families, and school communities through an optimized, multi-tiered focus on
contextual, behavioral, and individual systems. We focus the ACCESS center on testing effectiveness-
implementation models of school-based prevention during the middle school years, a time when escalating
rates of mental health distress in early adolescence culminate in mental health and behavioral disorders that
can last a lifetime. Our center is guided by 3 primary aims: 1) Accelerate knowledge and dissemination of
effective school-based interventions and practices; 2) Promote the center as a national resource on school-
based interventions for mental health; and 3) Promote innovative analytic and data harmonization methods that
accelerate the understanding of implementation mechanisms for and dissemination of school-based mental
health intervention programs and practices. Supported by an Administrative Core and a Methods Core, our
goal is to provide an overarching framework for both community and scholarly engagement and training as well
as methodological support. Led by Drs. Stormshak and Seeley and building on our decades-long history of
school-partnerships to promote mental health, the ACCESS center is composed of a transdisciplinary team
that will support engagement with our school partners and a scientific advisory board. We will conduct research
studies and pilot studies in mental health prevention that include opportunities for training early career
scholars. A robust plan for dissemination of our results will provide rapid deployment opportunities for schools
and communities across the US. Our Methods Core will support the design and testing of intervention and
implementation mechanisms for school-based prevention programs and practices, including coordination of
common data elements (CDE) and harmonization of data across projects. The Signature Project includes an
adaptive SMART design delivered by school providers that will evaluate both a school- and family-level
prevention model with targeted outcomes on systemic (school), family, and youth outcomes. Projects 1 and 2
test digital health models at the individual level to improve mental health outcomes through improvements in
emotional regulation (P1) and healthy technology use (P2). Project 3 leverages a University of Oregon initiative
in mental health prevention to test an innovative approach to develop workforce training and support for
school-based providers to deploy evidence-based practices for improving youth mental health. Our ultimate
goal is to transform delivery of school-based mental health promotion in adolescence and serve as a national
resource for schools, researchers, and other providers as we seek to reduce mental health distress and
behavioral problems from childhood through the young adult years.

Public health relevance
OVERALL PROJECT NARRATIVE Youth mental health distress rates are unacceptably high and there is no national model for the acceleration, evaluation, and dissemination of school-based prevention programs to reduce the risk of mental health distress in early adolescence. The ACCESS center at the University of Oregon will conduct effectiveness- implementation evaluations of interventions and practices that are delivered by real-world providers in schools and will increase scientific understanding, public awareness, and delivery of effective school-based interventions that prevent and reduce mental health distress during early adolescence to help fill his gap. Our research will have high public health impact by transforming the national model of mental health promotion in middle schools to reduce the risk of mental health disorders that have lifetime consequences.